Goal concordance in rheumatoid arthritis in diverse populations

? DESCRIPTION (provided by applicant): This K23 Mentored Patient-Oriented Research Award will provide additional training and practical experience for the candidate, Dr. Jennifer Barton. Dr. Barton is a rheumatologist who practices at a public hospital and has developed a research agenda around patient-clinician communication and health disparities. To further develop her career and achieve the goals of her research plan, Dr. Barton requires additional training in three areas: 1) qualitative research methods, 2) collaboration with measurement experts, health IT, and communication experts in development of a patient-reported tool, and 3) advanced biostatistical methods. Dr. Barton has assembled a multidisciplinary team to assure her success in achieving the goals of this award. Specifically, her primary mentor Dr. Edward Yelin, an expert in health services research in the rheumatic diseases, and co-mentor, Dr. Dean Schillinger, an internationally recognized expert in health communication with extensive expertise in implementing interventions among vulnerable populations, are uniquely situated to oversee Dr. Barton's training plan and execution of the research strategy. Dr. Patricia Katz, an expert in measurement science at UCSF; Dr. Victor Montori, a Mayo Clinic investigator and expert in the design of tools to share knowledge in the clinical encounter; Dr. Liana Fraenkel, a rheumatologist and health services researcher with extensive experience in patient preference and decision making; Dr. Somnath Saha, OHSU researcher in health communication and racial disparities in chronic disease; and Dr. Stuart Gansky, a UCSF biostatistician with experience analyzing data from observational studies of diverse populations, will provide support, expertise, and unique perspectives to Dr. Barton. Despite advances in treatment options and strategies for rheumatoid arthritis, significant disparities in outcomes among ethnic minorities and non-English speakers persist. Effective patient-clinician communication is central to the diagnosis, appropriate treatment, and avoidance of unsafe use or misuse of costly, potentially toxic therapies. Despite the need for a trusting partnership between patient and doctor to manage RA, goal- setting remains an unexplored domain, especially among patients who face barriers to communication. Therefore, in Aim 1, Dr. Barton will develop a measure of patient-clinician goal concordance; assess the extent and predictors of goal concordance using a mixed methods approach. In Aim 2, Dr. Barton will evaluate whether goal concordance is associated with trust, RA self-efficacy, quality of life, and medication adherence. In Aim 3, she will develop and pilot-test an intervention to enhance the elicitation of patient goals and conduct a larger, randomized trial of the intervention. This project will deepen our understanding of goal concordance in RA, as well as provide necessary training and practical experience to ensure Dr. Barton's success as an independent clinical investigator, and provide the basis of an RO1-application to evaluate an intervention to improve patient-clinician communication and quality of care in RA.

Public health relevance
PUBLIC HEALTH RELEVANCE: Significant disparities in outcomes among ethnic minorities and non-English speakers with rheumatoid arthritis (RA) persist despite significant advances in therapy and treatment strategies. One potential mechanism for these disparities is suboptimal communication around goals for therapy. We will evaluate the degree and impact of goal concordance on outcomes in RA, and develop and test the effectiveness and feasibility of an intervention to improve communication among vulnerable populations with RA and their clinicians.